HPV Cancer Prevention Project

PROJECT SUMMARY
This project was developed in partnership with and supported by IHC leaders and the Tribal
Council. It will actively use a community-engaged research approach, which helps ensure IHC-
centric leadership and direction. As such, there is high probability that study findings will be
relevant to IHC clinical and public health practice, allowing for rapid effective dissemination, and
sustainability. This research is significant in that it addresses the extremely low cervical cancer
screening rates among AI/AN women and the low HPV vaccination rates in adolescents. The
proposed multi-level intervention in low-resource health care settings in Southern California has
potential to provide scalable and sustainable solutions for cervical cancer prevention and HPV-
related malignancies that could be adopted.
Page 1

Public health relevance
PROJECT NARRATIVE Cervical cancer is the most frequently diagnosed cancer in American Indian/Alaska Native (AI/AN) women, who are nearly twice as likely to develop cervical cancer compared to non- Hispanic white (NHW) women and four times as likely to die from it. While implementation strategies and relevant evidence-based interventions (EBIs) exist to increase screening, few have been tested in AI/AN populations. Furthermore, few health care settings have adopted these EBIs, and their evaluation is limited. AI/ANs cite a number of barriers to cancer screening including cultural reluctance to access Western medicine for non-acute health problems; transportation difficulties; lack of childcare; and negative perception of health providers. Enabling factors, however, include access to female health professionals (including Indigenous health workers), and locally devised health plans that aim to improve access, health provider knowledge, recall systems, targeted culturally relevant health promotion, and population registers. Similarly, low HPV vaccination rates among Native communities call for locally and culturally relevant information and education efforts. Recent studies suggest that low-cost, targeted, multipronged approach[es] may be effective in Native communities to increase both vaccination and screening rates, and emphasize the importance of indigenous leadership in both cancer prevention planning and promotion within the community. This is consistent with recommendations by the US Community Preventive Service Task Force (USCPSTF) for multicomponent (individual demand, provider delivery, access) and multilevel (i.e., patient, provider, health system) EBIs. To address this gap, we propose to use Implementation Science to assess the implementation and effectiveness of the existing cervical cancer screening strategies and EBIs in a community health center serving AI/AN patients.